Expanded Pilot and Feasibility Award Program

REGIONAL PILOT AND FEASIBILITY AWARD PROGRAM: PROJECT SUMMARY/ABSTRACT
This application seeks to develop a Regional Pilot and Feasibility (P&F) Award Program to promote research
and collaborative investigations at institutions neighboring the SDRC. Stanford University is located in northern
California and neighbors other elite research institutions with significant research focused on diabetes. This
includes the nearby campuses of the University of California (UC) at Berkeley and UC Davis. This Regional
P&F program will support proposals for diabetes-related research from principal investigators at UC Davis and
UC Berkeley. This Regional program builds on the outstanding development and outcomes of the SDRC P&F
Award Program over the past 5 years, and is motivated by evidence of stellar research bases at UC Berkeley
and UC Davis with strong interests in developing ties to the SDRC and fostering diabetes research at their
institutions. The SDRC has developed strong scientific and training connections to these neighboring research
institutions. Thus, creation of a Regional P&F program that includes our UC colleagues is a natural extension
of the SDRC mission to support outstanding and innovative diabetes research by a cadre of superb scientists,
who lack their own DRC. The aims of the Regional P&F Award Program are: 1: To solicit, review, and fund a
northern California Regional P&F award program that includes diabetes researchers at UC Davis and UC
Berkeley. The Regional P&F program will support research proposals from UC Davis and Berkeley early
career investigators, investigators who are new to the diabetes research field, and established diabetes
researchers with ideas for novel and exciting research directions that have outstanding potential to open areas
of diabetes-related research in diverse scientific disciplines. In addition, interdisciplinary and inter-institutional
proposals will be encouraged, though proposals by PI’s at UC Berkeley or Davis can involve collaborations
with investigators from any other appropriate research institution. These grants will be provided to outstanding
investigators at UC Davis and Berkeley, whose research has a high probability of benefiting from use of SDRC
core facilities, and could generate data necessary to transition to additional extramural peer-reviewed funding
mechanisms. The successful execution of an initial Regional P&F award cycle in 2020-21 demonstrates the
rationale and feasibility of this expansion. 2: To provide mentorship and career development for recipients of
Regional P&F grants. The SDRC seeks to provide intellectual support and career development during the
project period. This activity aims to foster the P&F grantee’s scientific expertise and integrate scientific and
professional outcomes into the larger sphere of SDRC and national or international diabetes research. This
includes building relationships that enhance further collaboration between P&F award applicants or awardees
and other members of the SDRC. Fostering career development through the Regional P&F award program
should increase the broader impacts of the SDRC on diabetes research, including diversity among those
leading or performing diabetes research.